ARTERIAL BLOOD GAS MONITORING SYSTEM

The purpose of the study is to establish the feasibility of measuring arterial blood gases (i.e., oxygen and carbon dioxide) and pH in humans with micro-miniature electrochemical sensors. The sensor is passed through a standard 20-g catheter threaded into the radial artery, and continuous measurements are obtained. Results are compared to standard arterial blood gases drawn intermittently from the arterial line.